Regulation of the cGAS-STING pathway by RNF11

ABSTRACT
The cGAS-STING pathway is essential for DNA sensing and plays vital roles in host immunity to pathogens
and anti-tumor responses. Activation of cGAS-STING needs to be tightly controlled to promote immunity to
pathogens and tumors but prevent unrestrained or chronic inflammation that could be detrimental to host
fitness. Given that dysregulated or aberrant activation of cGAS-STING by host DNA has been linked to
autoimmunity, autoinflammatory diseases, neurodegenerative diseases, and aging-related chronic
inflammation, understanding the mechanisms of the negative regulation of cGAS-STING is of critical
importance. After binding to its ligand 2’3’-cGAMP, STING traffics from the endoplasmic reticulum (ER) to the
Golgi apparatus via coat protein complex II (COPII) vesicles. At the trans-Golgi, STING activates the kinase
TBK1 and the transcription factor IRF3 to induce type I interferon (IFN). To ensure transient cGAS-STING
activation, STING is sorted post-Golgi by the adaptor protein complex 1 (AP-1) into clathrin-coated vesicles
which become encapsulated by lysosomes via ESCRT-mediated microautophagy triggering STING
degradation. However, the precise mechanisms controlling COPII-dependent STING trafficking and its
negative regulation are largely unknown. In preliminary studies for this exploratory proposal, we provide
evidence that the endosomal RING-domain E3 ubiquitin ligase RNF11 functions as a negative regulator of
STING activation. RNF11-deficient bone marrow-derived macrophages (BMDMs) exhibit more rapid STING
degradation and enhanced STING-induced type I IFN and proinflammatory cytokines. Because RNF11
localizes to early and recycling endosomes and can regulate vesicular trafficking of proteins through COPII
vesicles, we hypothesize that RNF11 negatively regulates COPII-mediated STING trafficking from the ER to
the Golgi. The goals of this project are to determine the mechanisms of RNF11 regulation of STING (Aim 1),
and the role of RNF11 in inhibiting a STING-induced inflammatory response (Aim 2). We anticipate that
completion of these studies will provide new insight into the negative regulation of the cGAS-STING pathway
which could advance cancer immunotherapies and lead to new treatment strategies for autoimmune,
autoinflammatory, and neurodegenerative diseases.

Public health relevance
NARRATIVE RNF11 is an E3 ubiquitin ligase that localizes to endosomes and regulates intracellular protein trafficking and signal transduction pathways. This proposal seeks to understand how RNF11 negatively regulates the cGAS- STING DNA sensing pathway to prevent unrestrained or chronic inflammation that could lead to autoimmune, autoinflammatory and neurodegenerative diseases. Completion of the studies will provide new insight into the negative regulation of the cGAS-STING pathway that is important for the resolution of inflammation and rebalancing of immune homeostasis.